Ethical Approaches to Informed Consent for Autonomous Robotic Assisted Surgery

PROJECT ABSTRACT
Surgery is on the verge of a paradigm shift towards autonomous robot-assisted surgeries (RAS).
Increasingly, RAS is incorporating artificial intelligence (AI) algorithms to automate parts of surgery, allowing
computer algorithms to make critical decisions during surgery and directly affecting patient care. Autonomous
RAS raises new ethical concerns relating to changes to surgeons’ professional autonomy, informed consent,
confidentiality/privacy, and the surgeon-patient relationship. The use of autonomous RAS transforms surgeons’
professional autonomy in the operating room by introducing an independent entity in surgical decision-making.
The surgeon’s role shifts from being the principal decision-maker to collaborating with the robot or providing
oversight of the robot’s actions. Informed consent to autonomous RAS requires new ethical deliberations and
information disclosures given that the robot may be making critical decisions during surgery. New ethical
issues, including protecting the privacy of RAS-collected patient data, will need to be added in informed
consent discussions for autonomous RAS to ensure the surgeon-patient relationship remains human-centered.
Although no RAS is fully autonomous today, surgical robots are being endowed with increasing levels of
autonomy. Ethical guardrails and guidelines on how to inform patients about autonomous RAS must be in
place before autonomous RAS should be disseminated for widespread use. While the few available studies
found that patients may be “apprehensive” about undergoing autonomous RAS, little is known about the
factors shaping patients’ decision-making. A survey study of 11,004 American adults found that 59% would not
want AI-powered robots to be used in their own surgery. Further, no empirical studies have investigated
patients’ information needs to facilitate informed consent for the adoption of this innovative surgical technique.
The objective of this study is to examine ethical issues in autonomous RAS. We will examine
surgeons’ and patients’ perceptions of ethical issues involved in performing and undergoing autonomous RAS,
and factors affecting patients’ decisions about undergoing autonomous RAS. We will develop educational
materials to facilitate surgeon-patient communication about autonomous RAS and the management of
surgeon-patient relationships throughout pre-, intra-, and post-robotic care. The specific aims are to:
1) Assess surgeons’, proceduralists’, and nurses’ perceptions of ethical issues in autonomous RAS
2) Assess surgical patients’ decision-making for undergoing autonomous RAS
3) Develop educational materials to foster patients’ informed decisions about autonomous RAS
The impact of the proposed study will be a better understanding of ethical issues of autonomous RAS to
facilitate surgeon-patient communication and ensure that the surgeon-patient relationship remains human-
centered. Our results will facilitate the adoption of innovative surgical techniques through autonomous RAS.

Public health relevance
PROJECT NARRATIVE Artificial intelligence-driven robot-assisted surgery raises new ethical concerns relating to changes to surgeons’ professional autonomy, informed consent, confidentiality/privacy, and the surgeon-patient relationship. This study aims to examine ethical issues of informed consent and assess patient decision making for autonomous robot-assisted surgery. The impact of the proposed study will be to facilitate the adoption of innovative surgical techniques by better understanding ethical issues regarding autonomous robot-assisted surgery and guiding surgeon-patient communication so that the surgeon-patient relationship remains human-centered.